Bay Area Tumor Institute NCI Community Oncology Research Program (NCORP) Community Sites

Project Summary/Abstract
This BATI-NCORP program is designed to provide cancer patients, and healthy citizens “at risk”
for cancer, with opportunities to participate in NCI-sponsored clinical trials developed by the
members of the National Clinical Trials Network (NCTN) and NCORP Research Bases. These
clinical trials are intended to identify more effective and/or less toxic treatments for the
prevention, detection, diagnosis, treatment, long-term supportive care, or end-of-life care for
cancer patients. Via the BATI-NCORP, East Bay oncologists can provide their patients, at no
cost, with opportunities to participate in the most advanced and promising forms of genetic
therapy, immunotherapy, chemotherapy, surgery and radiation treatments.

Public health relevance
Project Narrative Since 2014, BATI has led the NCORP (NCI-Community Oncology Research Program) in the East Bay. This program conducts research in Cancer Care Delivery, Cancer Control and Prevention, and Cancer Therapeutics. BATI is the core member of this eight-member consortium of hospitals and private medical practices. It is responsible for all organizational, administrative and programmatic segments of the NCORP. BATI has the necessary financial, administrative and organizational strength to adapt to constant changes in the healthcare environment and the nation-wide evolution of community-based clinical research. The BATI-NCORP provides cancer patients, and healthy citizens “at risk” for cancer with opportunities to participate in NCI-sponsored clinical trials designed by members of the National Clinical Trials Network (NCTN) and NCORP Research Bases. These clinical trials are designed to determine more effective and/or less toxic treatments for the prevention, detection, diagnosis, treatment, long-term supportive care, or end-of-life care for cancer patients. Via the BATI- NCORP, East Bay oncologists can provide their patients, at no cost, opportunities to participate in the most advanced and promising forms of genetic therapy, immunotherapy, chemotherapy, surgery and radiation treatments. Fifty-six percent of all patients in the BATI-NCORP are members of low income or historically underserved minority populations.